Prevention of Postpartum Smoking Relapse and Related Health Consequences by Breastfeeding Promotion

PROJECT SUMMARY/ABSTRACT
About 14% of U.S. mothers smoke before pregnancy, and 54% of them report quitting spontaneously during
pregnancy. However, large numbers of mothers who quit during pregnancy return to smoking (“relapse”) after
delivery, e.g., 45% and 81% relapse by 6 and 12 months postpartum, respectively. Postpartum smoking
relapse not only limits the benefits of smoking abstinence to the mother, but also has serious negative
consequences for child health and development through secondhand smoke exposure. There is only limited
success in preventing long-term (9 months or longer) postpartum smoking relapse by existing interventions.
Breastfeeding mothers tend to have a lower risk of postpartum smoking relapse than formula-feeding mothers,
although the causality of this association is unclear. It is possible that ex-smoking mothers who are less likely
to relapse choose to breastfeed longer. But the reverse may also be true, i.e., mothers who breastfeed may be
less likely to relapse, partly due to the hormonal, emotional, and mother-infant relationship benefits resulting
from breastfeeding. A randomized controlled trial to reduce postpartum smoking relapse by promoting
breastfeeding may not only move the field forward by addressing the uncertainty of causality but also yield a
new approach to reducing the large public health problem of postpartum smoking relapse.
We propose a randomized controlled trial to reduce postpartum smoking relapse by breastfeeding
promotion from late pregnancy to 12 months postpartum. We will enroll 280 pregnant mothers who
successfully quit smoking during this pregnancy (≤28 weeks). After the pre-test, participants who are still
smoking abstinent will be randomized into either the breastfeeding intervention group (N=140) or the attention
control group (N=140). The intervention group will receive a multicomponent intervention consisting of
breastfeeding education, lactation counseling, social support, contingent financial incentives, and early limited
formula milk via syringe feeding (optional for at-risk infants). The control group will receive counseling and
support focusing on general infant care, with attention and monetary earnings similar to the intervention group.
Both groups will receive usual care (i.e., information, education, and Quitline) for postpartum smoking relapse.
The outcomes are postpartum smoking relapse, breastfeeding practices, and maternal and child health.
Aim 1 is to examine the efficacy of breastfeeding promotion intervention on postpartum smoking
relapse. Aim 2 is to examine potential mediating mechanisms: reductions in stress and negative affect,
enhancing mother-infant bonding and maternal sensitivity, and maternal weight retention. Aim 3 is to assess
the effects of breastfeeding promotion intervention on maternal and infant health among ex-smoking mothers.
This innovative study can yield promising data to support a new intervention to prevent postpartum smoking
relapse. It has the potential to reduce smoking-related harms to both the mother and the infant, maximize the
protective effects of breastfeeding on infant health and development, and narrow health disparities.

Public health relevance
PROJECT NARRATIVE As a very common phenomenon, postpartum smoking relapse not only limits the benefits of smoking abstinence to the mother but also adversely impacts child health and development through secondhand smoke exposure. The objective of this randomized controlled trial is to examine the efficacy of a new intervention to prevent postpartum smoking relapse and related health consequences by breastfeeding promotion. Our research has important implications for maternal and child health, especially given the scarcity of successful intervention programs to address the large public health issue of postpartum smoking relapse.